Integrated Omics Analysis of Pain: Omics Data Generation Center

SUMMARY
Acute pain, usually triggered by tissue injury, such as trauma or surgery, can lead to long-­term persistent chronic
pain, a debilitating condition that requires extensive treatment and pain management. Interestingly, the molecular
basis of this transition from acute to chronic pain is poorly understood, and this lack of knowledge impedes the
development of better treatment strategies for patients with chronic pain. Several recent studies have begun to
explore underlying genetic and molecular signatures of the conversion to chronic pain, but clearly, additional
efforts are needed to better understand the mechanisms and molecular signatures in a wider range of
surgery and trauma patients.
The goal of the NIH Acute to Chronic Pain Signatures (A2CPS) program is to determine the mechanisms that
make some people susceptible and others resilient to the development of chronic pain. We propose an Omics
Data Generation Center (ODGC) for the A2CPS Consortium as a collaborative effort of three academic
institutions with complementary technical expertise, experience in large-­scale data generation projects, and
established collaborations and interactions:
· Wake Forest University Health Sciences (WFUHS),
· The University of California at Davis (UCD), and
· Duke University School of Medicine (Duke).
The ODGC will generate omics data for blood samples collected from study participants at three clinical
assessments (0, 3, and 6 months after a surgical procedure or musculoskeletal trauma) for an integrated analysis
to identify biomarker signatures that are predictive of the transition from acute to chronic pain, and help reveal
the underlying pathophysiological mechanisms mediating this transition.
We have assembled a team of scientists that will use cutting-­edge technologies to perform high-­throughput
analyses in 1) proteomics (WFUHS and Duke), 2) metabolomics (WFUHS and UCD), 3) lipidomics (UCD),
4) extracellular RNA (WFUHS), and 5) SNP genotyping (WFUHS). In addition, we propose to examine the
epigenetics (DNA methylation) of monocytes collected from a subset of converters and non-­converters.
The resulting data will be integrated with extensive clinical assessment data, in collaboration with the Data
Integration and Resource Center and the Multisite Clinical Centers of the A2CPS Consortium.

Public health relevance
We propose to develop an Integrated Omics Data Generation Center (ODGC) as part of the overall Acute to Chronic Pain Signatures (A2CPS) consortium. The goal of our Center is to use cutting- edge methods to generate the required omics data (metabolomics, lipidomics, proteomics, extracellular RNA, and genetic variants), in addition to DNA methylation analysis in isolated monocytes, towards identifying the biological signatures and potential mechanisms for the transition from acute to chronic pain in the A2CPS cohort. We have assembled a team of investigators from Wake Forest University Health Sciences, the University of California, Davis, and Duke University with outstanding expertise to coordinate sample collection and shipping, generate and analyze omics data, and transfer the quality- controlled, finalized data set to the Data and Integration Resource Center (DIRC) of the A2CPS Consortium.